Unique Role of ASPM in Development of Large and Folded Cerebral Cortex

PROJECT SUMMARY/ABSTRACT
Neurodevelopmental disorders affecting the large and folded (gyrencephalic) human cerebral cortex require
disease mechanisms that are robust in humans but insignificant in mice. For example, loss of ASPM (assembly
factor for spindle microtubules) in humans causes severe microcephaly with 50-75% reduction in cortical volume,
simplified gyri, epilepsy, and intellectual disability. In contrast, Aspm KO mice show <10% reduction. ASPM
encodes a conserved centrosomal protein that regulates progenitor proliferation, delamination, and
differentiation. Thus, it is unclear how loss of a neurodevelopmental gene such as ASPM causes remarkably
severe phenotypes in the large, gyrencephalic human cortex compared to the mouse cortex. The ferret is a
genetically and surgically tractable, gyrencephalic carnivore that bridges the gap between human brain disorders
and mouse models. Its cortex shows transcriptional patterns similar to human cortex, and contains numerous
outer radial glia, a progenitor cell type abundant in humans but rare in mice. Our germline Aspm KO ferrets show
severe microcephaly with a 25-40% reduction in cortical volume and simplified gyri. Moreover, Aspm KO ferrets,
but not mice, show premature progenitor delamination and death. Importantly, ASPM KO human cerebral
organoids show the same progenitor defects as Aspm KO ferrets, as reported by the Vanderhaeghen lab
(Benthem et al., 2023). However, the molecular mechanisms by which only human and ferret progenitors are
uniquely susceptible to loss of ASPM are unknown. Our LONG-TERM GOAL is to elucidate the unique
developmental mechanisms of the large and gyrencephalic human cortex in health and disease. ASPM
microcephaly is a neurodevelopmental disorder for which human organoid, ferret, and mouse models are
available, making it an ideal candidate for investigating gyrencephalic mammalian-specific mechanisms. Our
CENTRAL HYPOTHESIS is that loss of ASPM triggers similar molecular changes in humans and ferrets, but not
in mice, via gyrencephalic mammalian-specific ASPM interactors. To test the hypothesis, we propose three
Specific Aims: (1) To systematically examine ferret and mouse cortical development in the presence and absence
of ASPM using spatial transcriptomics; (2) To determine molecular mediators of progenitor delamination and
death in ASPM KO human cerebral organoids and ferrets by comparing KO progenitors at one time point and
similarly delaminating WT progenitors at a later time point in human organoids and ferrets using single-cell RNA
sequencing; (3) To define the ASPM interactome in human, ferret, and mouse progenitors using proximity
labeling and centrosome proteome analysis. The roles of newly identified mediators of progenitor defects will be
tested in rescue experiments in ASPM KO human organoids and ferrets. With our strong expertise and cross-
species approach using human organoids, ferret and mouse models, we are uniquely qualified to rigorously
investigate gyrencephalic cortical development in health and disease.

Public health relevance
PROJECT NARRATIVE Loss of ASPM (assembly factor for spindle microtubules) significantly reduces cerebral cortical volume in humans and ferrets with premature progenitor delamination and cell death, but only slightly in mice without apparent progenitor defects, suggesting gyrencephalic mammalian-specific mechanisms. Our overall goal is to elucidate the unique developmental mechanisms of the large and folded human cortex in health and disease. Using wild-type and ASPM knockout human organoids, ferrets, and mice with state-of-the-art transcriptomic and proteomic techniques, we will test the central hypothesis that loss of ASPM triggers similar molecular changes in humans and ferrets, but not in mice, via gyrencephalic mammalian-specific ASPM interactors.